Pre-clinical Safety and Efficacy of Reversed Chloroquines

DESCRIPTION (provided by applicant): The worldwide health problem created by malaria has been made more difficult by the spread of drug-resistant parasites. This project addresses the need for new malaria drugs by initiating preclinical development of one or more candidate(s) from a new class of potent antimalarials. We have developed an orally available and inexpensive class of novel drugs that is expected to act against both chloroquine-resistant and chloroquine-sensitive malaria. We propose to advance a carefully-selected candidate through preclinical steps, leading to a pre-Investigational New Drug meeting with the Food and Drug Administration. With guidance from the FDA, steps that will likely include pharmacokinetics, pharmacodynamics, pharmacology, and toxicity evaluations will be performed in both rats and monkeys. The overall goal will be completion of studies leading to approval of the Investigative New Drug (IND) application for a drug to be used in a Phase-1 human clinical trial.

Public health relevance
Project Narrative Malaria is a disease that infects about half a billion people annually, and kills nearly one million, most of whom are children or pregnant women. The impact of malaria is increasing, partly because the parasite that causes malaria has evolved into strains that are resistant to the best current drugs for treating the disease. This project involves preclinical evaluation of novel drugs that are designed to circumvent this resistance, paving the way toward approval for human clinical trials.